IGF::OT::IGF: Constructed Environments for Successfully Sustaining Abstinence Through Immersive and On-Demand Treatment (CESSATION). September 30, 2018 - September 29, 2020. N44DA-18-5583. Base Award.

The Contractor shall continue to refine and fully validate Constructed Environments for Successfully Sustaining Abstinence Through Immersive and On-Demand Treatment (CESSATION).